Examining the Relationship between Executive Functioning and Cognitive Reappraisal Ability in Daily Life

PROJECT SUMMARY
The goal of this R15 Research Enhancement Award is to elucidate the role and impact of
executive functioning in relation to the use of cognitive reappraisal as an emotion regulation
strategy. Cognitive reappraisal is a key process in cognitive therapies and cognitive behavioral
therapy (CBT), the frontline treatment for anxiety and depression, but individuals are not always
successful at implementing reappraisal. We propose that executive functioning, a set of higher-
order cognitive abilities, may partly underly reappraisal success. This project is innovative in that
we will assess reappraisal ability (i.e., success) in a naturalistic context using experience
sampling methodology (ESM), a relatively new approach not previously used to study
reappraisal ability. Prior research has relied upon in-lab assessment, which has strong internal
validity but may lack external validity due to the controlled lab environment and narrow stimulus
sets, and limited ability to study the effect of reappraisal in daily life. In addition to these
scientific aims, this project emphasizes development of institutional research infrastructure and
student training through intentional and embedded training related to ESM and related
approaches. With a diverse, well-characterized, community-based sample of 150 adults, we will
assess the influence of reappraisal on emotional response to daily life stressors using ESM. We
will also examine the relationship between executive functioning and reappraisal ability in daily
life. By utilizing both ESM and an established in-lab reappraisal paradigm, we can establish
ground truth of the ESM approach to assessing reappraisal ability. If valid, this approach to
studying reappraisal could impact future research in this area. Additionally, findings could inform
intervention optimization. For example, if specific facets of executive functioning (e.g., limited
inhibition or shifting) impair use of reappraisal, intervention may be successfully augmented via
the addition of targeted training for executive functioning.

Public health relevance
PROJECT NARRATIVE Reappraisal is a core skill taught in most cognitive-behavioral and emotion processing interventions for psychiatric disorders, yet there is great variability in how effectively people utilize reappraisal, which may ultimately impact treatment outcome. Executive functioning, a set of semi-modifiable cognitive processes, may underlie one’s ability to engage in successful reappraisal. The goal of this study is to determine the degree to which executive functioning effects reappraisal ability in daily life naturalistically.